Real-time structural and functional studies of SARS-CoV-2 spike proteins

Abstract:
Spike glycoprotein (S-protein) is one of the viral transmembrane proteins on the envelope of severe acute
respiratory syndrome coronavirus 2 (SARS-CoV-2), which causes the coronavirus disease 2019 (COVID-19). S-
protein plays a crucial role in mediating the initial entry of viral genome into the host cell by binding to the human
angiotensin-converting enzyme 2 (ACE2) and then inducing fusion between the virus envelope and cell
membrane. Thus, S-protein is a target of choice for diagnostic and therapeutic assays, including neutralizing
monoclonal antibodies (nAbs). To date, the conformations of S-protein and its molecular assemblies with ACE2
and/or nAbs have been mainly determined by structural techniques, including crystallographic and electron
microscopic methods. These structural studies allow us to understand the molecular basis underlying viral entry
and to further develop treatment and preventive therapeutics for COVID-19. However, these resolved structures
are rather “static snapshots” compared to the dynamic nature of proteins in physiological conditions. Due to the
technical difficulties, our knowledge about the real-time structural dynamics of S-protein and its real-time
interactions with host receptors, nAbs, and the other relevant biomolecules, which may have functional
significance, is still very limited.
In this proposal, my lab will develop a bio-mimicking reconstitution system and apply a cutting-edge
structural imaging technique, high-speed atomic force microscopy (HS-AFM), for real-time observations of S-
protein’s structural dynamics in close-to-native environments and under various conditions. We will also develop
novel methods to quantitatively characterize the architecture of molecular assemblies comprising S-protein,
ACE2 receptor, nAbs, host proteases and enzymes, and biological membranes, which can mediate the
membrane fusion and viral entry processes. Specifically, we will identify the “real-time” structural dynamics of S-
protein in different states and visualize how the state transitions happen, for example, during ACE2 binding,
nAbs attachment, and the structural cleavages in S-protein subunits. My lab will further develop correlated
fluorescence microscopy and HS-AFM to study these dynamic events associated with S-protein on the
mammalian cell surface. The biophysical and biochemical information acquired in our proposed experiments will
provide a comprehensive molecular understanding of the conformational states of S-protein, intermolecular
interactions between S-protein and binding molecules (ACE2 and nAbs), the conformational changes in S-
protein for initiating membrane fusion processes for viral entry, and how the mammalian cell surface impacts the
S-protein. The developed methods here can further apply to the other receptor-mediated membrane fusion
systems for cell entry.

Public health relevance
Narrative Viral transmembrane spike glycoproteins binding to human receptors mediate the entry of SARS-CoV-2 to the host cell, which causes COVID-19. Despite their functional importance, the real-time structural and functional dynamics of spike proteins and their interactions with the other function-regulated biomolecules on host cells are still unknown. We will use state-of-the-art high-speed atomic force microscopy (HS-AFM) to directly visualize the real-time structural dynamics and intermolecular interactions in the spike protein system, which is critical for understanding the molecular mechanism of receptor-mediated virus entry.